Data Coordinating Center for the Pediatric Heart Network

PROJECT SUMMARY/ABSTRACT
New England Research Institutes, Inc. (NERI) is applying to continue its 15-year role as the Data
Coordinating Center (DCC) for the Pediatric Heart Network (PHN). The PHN is a cooperative network of Core
and Auxiliary Clinical Centers, a DCC, and National Heart, Lung and Blood Institute (NHLBI) Project Scientists.
The objectives of the PHN DCC are to 1) manage study development, launch, and dissemination of results; 2)
manage core PHN operations; and 3) coordinate logistics and other support services. As the DCC, NERI will
provide robust scientific oversight and proven logistical support for the next cycle of the Network, with key
responsibilities and functions for leadership in project management of the Network, overall study coordination
and efficient management of data acquisition; leadership in development and deployment of innovative
infrastructure and tools; electronic information and data systems; logistical and support services; novel study
design and statistical methodologies; and management and distribution of Network funds. Our proposed
approach presents a strong experienced NERI team, which builds upon decades of successful close
collaboration with NHLBI, and ensures efficient scientific and administrative support to the PHN, using 21st
century technologies.
A multiple PI leadership plan is proposed to continue the leadership roles shared by Ms. Miller (Network
Operations) and Dr. Stark (Statistics), with clearly delineated roles and responsibilities for leading and directing
the DCC.

Public health relevance
PROJECT NARRATIVE The mission of the Pediatric Heart Network is to improve health outcomes in patients with pediatric acquired and congenital heart disease; disseminate collaborative findings as the basis for improved evidence- based treatment options and standards of care; train and educate new investigators, and provide support and advocacy for families during the conduct of excellent, ethical clinical research. The Data Coordinating Center provides the network infrastructure to support this research.